EASTERN COOPERATIVE ONCOLOGY GROUP

The purpose of this grant application is to support Mayo Clinic membership in the Eastern Cooperative Oncology Group (ECOG). The goals are directed toward a greater understanding of cancer, a better understanding of cancer-related problems, development of improved cancer treatment programs, and improved cancer-patient survival. Mayo Clinic at its three campuses in Rochester, Minnesota, Jacksonville, Florida, and Scottsdale, Arizona, has the resources, personnel, facilities, and patient population to facilitate strong contributions to the research programs of ECOG. With the continued growth and development of the Mayo medical practice and continuing North Central Cancer Treatment Group (NCCTG) activities, we would anticipate significant protocol entry and scientific contribution. This ECOG affiliation and treatment programs which have evolved provide major benefits to Mayo Clinic, its investigators, regional cancer programs, and the large group of cancer patients who are involved in these research activities. The specific aims of this grant proposal are to support the following aspects of Mayo Clinic ECOG research activities including: 1. Patient accrual to group-wide ECOG cancer treatment protocols 2. The evaluation of new protocol design and treatment regimens to provide background clinical data to justify group wide ECOG Phase II and III cancer treatment protocols 3. Coordination of and participation in adjunctive laboratory-based correlative studies in association with ECOG cancer treatment protocols 4. Participation in disease-specific activities and such administrative roles as might be appointed and appropriate.